Dynamics and mechanisms of long-range enhancer activity

Project Summary/Abstract
Proper spatiotemporal gene expression is fundamental to all biological processes. Cell-type-specific gene
expression programs are driven in large part by enhancers, which are cis-regulatory sequences that determine
when and where genes are activated in a cell-type-specific manner. Enhancers often have to regulate genes
across large genomic distances, but the molecular mechanisms underlying long-range enhancer-promoter (E-
P) interactions remain unclear. Cell-type-specific regulators are also often regulated by enhancer clusters, which
have been proposed to activate target genes via a condensate mechanism. The goal of this proposal is to
understand the mechanistic basis of individual and clustered enhancers in human cells.
The MYC locus is uniquely suited to address questions about enhancer function because it is regulated
by different enhancers in different cell types. In several cancers including lung and endometrial cancers, the
respective MYC enhancers are focally amplified to form enhancer clusters, which is thought to drive MYC
overexpression. In Aim 1, super-resolution live-cell imaging (SRLCI) will be employed to simultaneously
visualize MYC E-P interactions and nascent transcription over time in living lung and endometrial cells,
which utilize different enhancers located ~450kb and ~800kb downstream respectively. To further validate that
the inferred models from SRLCI are accurate, perturbations to key molecular players will be performed followed
by SRLCI. By integrating 3D genomics and polymer simulations, the proposed research will generate quantitative
models of how different enhancers regulate the same promoter. In Aim 2, the hypothesis that enhancer
clusters activate transcription via a condensate mechanism will be tested. Additional enhancers will be
introduced in both lung and endometrial cell lines to generate enhancer clusters, and SRLCI will be performed
to determine the mechanism underlying enhancer clusters. Similar to Aim 1, 3D genomics data will be
incorporated to generate polymer models of how enhancer clusters impact chromatin structure and E-P
interactions to drive transcription. Together, these aims will provide a comprehensive and quantitative
mechanistic understanding of how dynamic E-P interactions regulate transcription in two different cell types.
The proposed research will be conducted in parallel with career development training to develop the
necessary skillsets required to achieve the applicant’s goals of becoming an independent PI at a research
institution. In addition to experimental and computational training, the applicant will receive mentorship from both
sponsors on oral and written scientific communication, leadership, lab management and responsible conduct of
research. This will be complemented by the world-class academic environment in MIT’s Department of Biological
Engineering, Department of Physics and the Broad Institute of MIT and Harvard, where the applicant will be able
to take advantage of the wealth of resources to expand her conceptual understanding of transcriptional regulation
and learn to approach biological questions from an interdisciplinary, holistic viewpoint.

Public health relevance
Project Narrative Enhancers are cis-regulatory elements that control precise spatiotemporal gene expression in a cell-type-specific manner. Despite being discovered over 40 years ago, the fundamental mechanisms of enhancer activity are still not well understood. Here, we propose to study the mechanisms by which cell-type-specific enhancers activate genes over long distances using MYC as a model locus.